Circulating metabolites as novel risk biomarkers for gastric cancer: a large multi-center prospective investigation

ABSTRACT
Gastric cancer is one of the most common and deadly cancers globally, accounting for over one million new
cancer diagnoses and 783,000 deaths in 2018. Infection of Helicobacter pylori (H. pylori) is the most important
risk factor and a necessary cause for non-cardia gastric cancer. While targeting high-risk populations who are
infected with H. pylori seems a compelling strategy for gastric cancer screening and prevention, a significant
concern not addressed is that only ~1 to 3% of the H. pylori infected individuals develop gastric cancer, indicating
that a strategy based on H. pylori status alone is insufficient, particularly among populations with a relatively low
prevalence of H. pylori infection. Thus, discovering and validating additional biomarkers, especially non-invasive
ones, is necessary to facilitate the development of novel risk assessment tools for gastric cancer. The human
metabolome reflects endogenous responses to exposures, including environmental and lifestyle factors that are
related to carcinogenesis. The use of advanced metabolomics techniques in prospective population -based
cohort studies has successfully identified both novel etiologic factors and risk biomarkers for different cancers.
However, few prior studies have focused on identifying novel risk biomarkers for gastric cancer using
metabolomics techniques, particularly in prospective design settings. We recently conducted the first nested
case-control study within two large prospective cohorts. Our study identified 5 metabolites associated with risk
of gastric cancer after correction for multiple comparisons, and 13 additional metabolite candidates for further
investigations. These include metabolites related to vitamin B12 deficiency, green tea/coffee intake, and two
progestin steroids, representing a few biologically plausible mechanisms involved in gastric cancer etiology.
Herein, we propose to conduct a large prospective investigation within a newly formed international consortium
to validate these highly promising findings, as well as discovering novel risk biomarkers, using both untargeted
and targeted metabolomics approaches. Pre-diagnostic plasma samples and epidemiologic data including
demographics, lifestyle factors, and dietary intakes will be harmonized for ~1,200 incident cases and 1,600
matched controls from six prospective cohorts. The proposed study will incorporate a rigorous two-stage design
to screen and validate circulating metabolite biomarkers for gastric cancer risk in East Asians and European
Whites (Aim 1 & 2). Furthermore, we will assess mediating effects of the identified metabolites on the
associations between known risk factors and gastric cancer to facilitate the understanding of involved biological
mechanisms (Aim 3). Through aseries of rigorously designedresearch activities, fresh insights into mechanisms
of gastric carcinogenesis and novel biomarkers for future development of risk assessment tools are expected.

Public health relevance
PROJECT NARRATIVE Gastric cancer remains an important health burden in the United States and worldwide; its etiology is not fully understood and effective biomarkers for risk assessment are still lacking. Recent advancement in metabolomics techniques provides new opportunities for uncovering new etiologic factors and novel biomarkers to assist in identification of high-risk populations for gastric cancer, and ultimately improve disease prevention. To achieve these goals, we propose to conduct a comprehensive metabolomics study of gastric cancer risk with a multi- center, nested case-control design within a new international consortium.